Developing strategies to inhibit cancer immunotherapy-induced immune-related adverse events without impeding anti-tumor immunity

Project Summary/Abstract
Tumors elicit a range of suppressive mechanisms in order to evade the immune system. Many of these are
targetable as evidenced by the great success of cancer immunotherapies that boost a patient's own immune
response towards cancer. Often, targets for cancer immunotherapies represent pathways that at homeostasis
protect against activation of an immune response towards self, limiting the development of autoimmune
disease. Cancer patients treated with immune-potentiating therapies are exposed to significant risk of
developing immune-related adverse events (irAEs). These irAEs have been reported in nearly every organ
system, and in many cases represent non-resolving autoimmune side-effects that pose a significant impact
due to their potential morbidity, mortality and associated healthcare costs. With a growing number of
immunotherapies reaching clinical utility and increasing combination studies that may initiate more frequent
and severe irAEs, understanding which therapeutic approaches provide improved tumor control with minimal
side-effects is essential. In this study, by generating transplantable, syngeneic tumor cell lines in autoimmune-
prone NOD mice, which develop autoimmune pathologies in response to cancer immunotherapies, we may
begin to assess the interplay between irAEs and anti-tumor immunity. In-depth profiling of genetic, epigenetic
and cellular mechanisms that separate anti-tumor immunity versus autoimmunity in response to cancer
immunotherapies will be defined to better engineer therapeutic strategies that enhance the immune response
towards tumor with limited impact towards self. Using NOD tumors resistant to clinically-approved cancer
immunotherapies such as anti-PD-1 and anti-CTLA-4, combination therapeutic strategies that reinvigorate
immune activation in the tumor microenvironment will be identified and the associated risk for precipitating
irAEs determined. Together, these preclinical models provide a platform to assess safety profiles for cancer
immunotherapies, identifying mechanisms to inhibit or avoid irAEs while preserving anti-tumor immunity. This
research will be performed amongst world-class scientists and facilities at the University of California, San
Francisco, this environment will foster expert training in the analysis of high-dimensional datasets generated
from CyTOF and 10X single-cell RNA and TCR sequencing, an essential skill for delineating the complex
mechanisms contributing to immune-mediated disease. Both my mentorship committee, led by Dr. Jeffrey
Bluestone and expert collaborators will allow me to fulfil these research goals. Following, I will transition to an
independent position establishing a research program that integrates the effect of multiple environmental
factors, including microbiome, diet, age and stress, alongside autoimmune and anti-tumor immune responses
to cancer immunotherapy using the NOD tumor models that have been developed, with the ultimate aim to
improve safety, specificity and treatment efficacy for immunotherapy-treated cancer patients.

Public health relevance
Project Narrative Immunotherapies have revolutionized the treatment of cancer by improving survival benefit for patients in a number of cancer types, however, with increasingly complex treatment strategies being deployed in a variety of combinations, the risk for developing severe side-effects in the form of immunotoxicities is heightened. Through improved preclinical models, such as generating tumors in autoimmune-prone mice, we can better study the influence of immunotherapies on both tumor immunity and autoimmunity. This will address a growing need to provide accurate safety profiling and mechanistic interrogation of both combinatorial and single-agent therapies to determine optimal therapeutic regimens to improve cancer care with mimimal immune-related adverse-events.